Cardiac CT: Advanced Architectures and Algorithms

DESCRIPTION (provided by applicant): Cardiovascular diseases are pervasive with high mortality and morbidity at tremendous social and healthcare costs. There are urgent needs for significantly higher fidelity cardiac CT with substantially lower radiation dose, which is currently not possible because of technical limitations. Although cardiac CT technology has improved significantly from 16 to 320 detector rows and from single to dual source, there remain technical challenges in terms of temporal resolution, spatial resolution, radiation dose, and so on. Based on an ideal academic-industrial partnership between Virginia Tech and the GE Global Research Center (GEGR), we are motivated to advance the state-of-the-art in cardiac CT dramatically and define the next generation cardiac CT system. The overall goal of this project is to develop novel cardiac CT architectures and the associated reconstruction algorithms, and define the next-generation cardiac CT system. The specific aims are to (1) design, analyze and compare novel cardiac CT architectures with novel sources and scanning trajectories; (2) develop analytic and iterative cardiac CT reconstruction algorithms for ROI-oriented scanning and dynamic imaging for the proposed cardiac CT architectures; and (3) evaluate and validate the proposed architectures and algorithms in theoretical studies, numerical simulations, phantom experiments and observer studies. On completion of this project, we will have singled out the most promising cardiac CT architecture and algorithms to achieve 16cm coverage, 50ms temporal resolution, 20lp/cm spatial resolution, 10HU noise level, and 5mSv effective dose simultaneously for the entire examination, with detailed specifications and performance evaluation, setting the stage for prototyping a next-generation cardiac CT system in a Phase-II project. This project will make a quantum leap in cardiac CT, in the sense that our proposed cardiac CT technology will enable significantly better diagnostic performance and bring major therapeutic benefits that affect 61.8 million Americans.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cardiovascular diseases are pervasive with high mortality and morbidity at tremendous social and healthcare costs. Cardiac CT technology needs major improvements to capture a fast beating heart with better image clarity at lower radiation dose. The overall goal of this project is to develop the next generation cardiac CT architecture and algorithms for significantly superior diagnostic performance and therapeutic outcomes that affect 61.8 million Americans. Project Narrative Cardiovascular diseases are pervasive with high mortality and morbidity at tremendous social and healthcare costs. Cardiac CT technology needs major improvements to capture a fast beating heart with better image clarity at lower radiation dose. The overall goal of this project is to develop the next generation cardiac CT architecture and algorithms for significantly superior diagnostic performance and therapeutic outcomes that affect 61.8 million Americans. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Cardiovascular diseases are pervasive with high mortality and morbidity at tremendous social and healthcare costs (http://www.americanheart.org/). As a result, the use of cardiac imaging has increased dramatically in hospitals and clinics. There are urgent needs for significantly higher fidelity cardiac computed tomography (CT) with substantially lower patient dose, which cannot be achieved by current technologies. Ideally, both spatial resolution and temporal resolution of cardiac CT should be improved so that all details of the anatomy can be visualized accurately and dynamically. One of the major factors that limit the image quality is the cardiac motion, which introduces blurring and artifacts. Although conventional CT technology has improved significantly from 16 to 320 multi-detector rows, with focal spot wobble, increased rotation speed, improved source flux, and the dual-source configuration, there remain performance challenges in terms of temporal resolution, spatial resolution, and patient dose. Hence, we are motivated to advance the state-of-the-art in cardiac CT dramatically to improve structural and functional imaging at significantly reduced patient dose. The purpose of this project is to develop novel cardiac CT architectures and the associated reconstruction algorithms, and to demonstrate their feasibility and utility. The specific aims are as follows: Aim 1 - Architecture Innovations: Design, analyze and compare novel cardiac CT architectures with novel sources and scanning trajectories. Multiple novel cardiac CT concepts will be investigated, including the representative ones published by us and others: base-line architectures (third-generation CT, dual-source CT, and electron-beam), saddle-curve scanning architectures (line-source CT and composite-circling CT), the triple-source architecture, arc-source architectures (including inverse geometry CT), nanotube-based architectures, interior imaging schemes, and instant/ultrafast CT architectures. Based on the clinical requirements, the key performance indexes are defined as 16cm coverage, 50ms temporal resolution, 20lp/cm spatial resolution, 10HU noise level, and 5mSv effective dose for the entire examination. We will define a limited number of specific cardiac CT architectures and perform a detailed design. We will compare those based on engineering analysis and numerical simulation and select the two most promising architectures. These will then be targeted in a more detailed algorithm development (Aim 2) and performance evaluation (Aim 3). Aim 2 - Algorithm Development: Develop analytic and iterative cardiac CT reconstruction algorithms for ROI-oriented scanning and dynamic imaging with two selected cardiac CT architectures. Over the past several years, researchers have extensively studied exact cone-beam reconstruction algorithms. Also, increasing computational capacity has promoted the application of iterative reconstruction algorithms. In this project, representative analytic and iterative algorithms - each with its own strengths and weaknesses - will be adapted to the proposed cardiac CT architectures with a strong focus o the compressive sampling framework. Then, for the two selected architectures we will extend the algorithms to the interior problem (reconstruction of an interior ROI from projection data along lines only through the ROI). Although the conventional wisdom states that the interior problem is not uniquely solvable, our recent theoretical and numerical results have demonstrated that this interior problem can be solved exactly and stably. This approach will be a key element to reduce radiation dose of cardiac CT. Furthermore, we will target the dynamic aspect of cardiac CT, incorporating a priori knowledge, motion estimates, and temporal weighting functions into the analytic and iterative algorithms, to optimize dynamic reconstructions. Aim 3 - Performance Evaluation: Evaluate and validate the selected cardiac CT architectures and the corresponding algorithms in theoretical studies, numerical simulations, phantom experiments and observer studies. The architectures and algorithms will be evaluated at four levels. First, a theoretical analysis of the system performance will be performed. For a given architecture and protocol, the system performance will be characterized in terms of fundamental measures, such as Radon completeness, intrinsic resolution, sensitivity and dose. Second, a more detailed evaluation will be conducted with numerical tests using the well-established comprehensive GE CT simulator CatSim. The competing reconstruction algorithms will be compared for the selected architectures in terms of major quality and dose indexes. Third, experiments will be done using a universal bench-top CT platform developed at GEGR to emulate the selected architectures and validate the associated algorithms with real projection measurements from various phantoms. This is to ensure all relevant physical effects are considered. Fourth, observer studies will be performed to evaluate the images from the experiment studies as well as the selected system designs. Based on the quantitative, observer and evaluative studies, we will have a very clear picture of these advanced cardiac CT scanners, and be ready to prototype a next-generation cardiac CT system in a Phase II project.